The 11th Annual PTCTC Educational Meeting, The First 100 Days After Stem Cell Transplant

PROJECT SUMMARY
We propose to organize and conduct the Eleventh (11th) Annual Pediatric Transplant and Cellular Therapy
Consortium (PTCTC) Meeting at the Seattle Convention Center, which is an indoor arena located in Seattle, WA,
on April 2, 2024. A unique aspect of the Annual PTCTC Educational Meeting is that it is jointly held with the
international American Society of Pediatric Hematology Oncology Conference (April 3-6, 2024) and includes a
Combined Plenary Session, bringing pediatric hematology oncology professionals together from around the
world. Hematopoietic cell transplantation (HCT) is a potentially curative therapy for many childhood illnesses.
Basic, translational, and clinical research advances have significantly increased non-relapse mortality after HCT.
The remarkable success is partly owed to the presentation, dissemination, and sharing of new knowledge at
annual meetings. This 1-day program will invigorate the field of pediatric HCT. The theme of the 11th Annual
PTCTC Educational Meeting will be “The First 100 Days”. The meeting will focus on transplant-related
complications and improving care during the first 100 days after HCT. Sessions focusing on transplant
complications will include presentations and discussions on endothelial injury (e.g., veno-occlusive disease and
thrombotic microangiopathy), infections, and acute graft versus host disease. The fourth session will be a
dedicated session analyzing the first 100 days from a patient's and parent’s perspective; the speakers will include
a transplant survivor and his dad. Finally, we will have a session dedicated to healthcare provider burnout. The
primary objectives include providing evidence-based guidelines to screen, recognize, and treat endothelial injury
after HCT through standardized strategies that can be implemented irrespective of the treating institution; II)
review the “state of the science” in acute GVHD immunology and management; III) provide clinically relevant
strategies to preserve the microbiome, and decrease infections after HCT; IV) enhance the understanding of
wellness, thereby maximizing long-term quality-of-life and survivorship of pediatric HCT patients and their
parents; V) review physician burnout and provide attendees meaningful strategies to recognize and prevent
burnout; VI) provide mechanisms to recognized to promote networking and collaboration of research and clinical
trials involving pediatric HCT patients. The results of the 11th Annual PTCTC Educational Meeting will likely
enhance our understanding of the basic, translational, and clinical state of the scientific research in the first 100
days after HCT, which will provide an opportunity and platform to engage young and senior clinicians and
scientists to develop collaborative research. The Organizing Committee will make every effort to enhance
diversity by increasing individuals from diverse backgrounds, including those from underrepresented groups.
Participation of trainees and underrepresented minorities is especially encouraged through travel awards.

Public health relevance
NARRATIVE This Tenth (11th) Annual Pediatric Transplant and Cellular Therapy Consortium (PTCTC) Educational Meeting on “The First 100 Days” after stem cell transplant will be attended by interdisciplinary clinicians and scientists, including minorities and underrepresented groups. The educational program will facilitate new knowledge in this field, promote collaborative research and enhance the maturation of young investigators in pediatric hematopoietic cell transplantation. Further, this conference will bridge the clinical and scientific gap between pediatric and medical HCT specialists treating children, adolescents, and young adults after stem cell transplant.